Enteroendocrine cells sense gut bacteria and activate a gut-brain pathway

PROJECT SUMMARY
Microorganisms residing in the intestinal lumen have a significant impact on brain function and behavior.
Perturbation of microbe-gut-brain communication is believed to be involved in the pathogenesis of well-known
gut-brain disorders such as irritable bowel syndrome (IBS) and related functional GI disorders. However, there
is lack of understanding of the precise microbial mechanisms and the cellular pathways that allow gut microbes
to communicate with the brain. To address this critical knowledge gap, the applicant has pioneered the zebrafish
system for the study of microbe-gut-brain communication. Using in vivo real-time measurements of cell activity
in zebrafish, the applicant’s recent research revealed that specific gut bacteria directly activate specialized
sensory cells in the intestine epithelium, enteroendocrine cells (EECs), through the receptor transient receptor
potential ankyrin A1 (Trpa1). Microbial, pharmacological, or optogenetic activation of Trpa1+EECs directly
activates enteric neurons and stimulates vagal sensory ganglia. Preliminary studies identified a distinct subset
of bacterial derived tryptophan catabolites as novel agonists that potently activate Trpa1. The objective of the
proposed research is to determine the precise molecular mechanism by which enteric bacteria activate the EEC-
vagal sensory pathway to modulate brain activity. The central hypothesis is that bacterial secreted tryptophan
catabolites stimulate Trpa1 in EECs to activate vagal sensory neurons through a novel EEC secreted signal
peptide, pituitary adenylate cyclase activating polypeptide (Pacap). To test this, the applicant will first use
molecular microbiology and zebrafish gnotobiotic approaches to define the microbial pathway and mechanism
that activates EEC Trpa1 signaling. Second, the applicant will use in vivo vagal calcium imaging, optochemical
and genetic manipulation to identify the specific subtype of EECs that transmit enteric bacterial information to
the vagus. Finally, the applicant will use pharmaceutical, genetic and cell transplantation approaches to define
the EEC signaling peptide that transmits bacterial information from the gut lumen to the vagus. The proposed
research is expected to make a significant new contribution to our understanding of the molecular mechanisms
and cellular pathways by which enteric bacteria communicate with the brain. The interdisciplinary experimental
approach together with the comprehensive career development plan will extend the applicant’s training from
gastroenterology into vagal and brain physiology as well as molecular microbiology. A diverse team of
established investigators at Duke University and UNC Chapel Hill, with expertise ranging from host-microbe
interaction to gut-brain physiology to bacteriology, will oversee the applicant’s career development during the
award period by contributing intellectually to her research training, providing mentorship, and offering career
advice. This 5-year career development award will provide the applicant with the necessary professional and
scientific skills to be an independent and successful microbiota-gut-brain scientist.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of mechanisms by which intestinal microorganisms influence the central nervous system is expected to lead to increased understanding and new treatments for many neurological diseases and functional intestinal disorders. The proposed research is therefore relevant to the part of NIH’s mission that pertains to developing fundamental new knowledge that will enhance health and reduce the burdens of illness.